Investigating cell-intrinsic and extrinsic interactions in prostate cancer at the single cell level

Project Summary/Abstract
Prostate cancer progression to metastatic castration-resistant disease continues to represent a major
health issue. Recent advances in single-cell approaches have revealed extensive heterogeneity and complexity
of cell states and cell types that drive tumor progression, and additional studies have demonstrated the central
role of the tumor microenvironment. Consequently, we are proposing a new Program Project to investigate the
interplay between tumor cells and their surrounding stromal and immune microenvironment in promoting prostate
cancer progression, metastasis, and treatment-resistance. Our proposal is highly integrated as it brings together
a multi-institutional team of four distinguished investigators (Michael Shen, Charles Sawyers, Cory Abate-Shen,
Massimo Loda) in the study of prostate cancer who have complementary expertise as well as a substantial track
record of collaborative interactions.
We have structured our application around the following projects and cores: Project 1, led by Charles
Sawyers (Memorial Sloan-Kettering Cancer Center), will investigate the immune and stromal factors that
promote prostate adenocarcinoma and castration-response. Project 2, led by Cory Abate-Shen (Columbia
University Irving Medical Center; CUIMC), will investigate the cell intrinsic and extrinsic drivers of prostate cancer
metastasis to bone. Project 3, led by Michael Shen (CUIMC), who is also overall PI, will analyze the intrinsic
and extrinsic factors that promote prostate neuroendocrine differentiation. Core A (Pathobiology), led by
Massimo Loda (Weill Cornell Medicine), will provide multiple pathology-based services to all three Projects.
Finally, Core B (Administrative and Data Management), led by Michael Shen, will support each Project through
data management, biostatistical support, and coordination of the overall program, resource management, and
review by the Internal and External Advisory Boards. Together, this highly synergistic program will elucidate the
integration of intrinsic and extrinsic signals that drive castration-resistance, metastatic tropism, and
neuroendocrine differentiation in prostate cancer, and will provide translational insights into the stromal and
immune microenvironments for improved therapeutic approaches.

Public health relevance
Program Narrative Despite many recent advances in treatment of prostate cancer, it remains a major cause of cancer-related death in American men. The investigators in our multi-disciplinary team will apply their complementary expertise to investigate fundamental mechanisms of prostate cancer progression, metastasis, and treatment resistance in order to provide new insights into molecular pathways and targets for improved therapeutics.